High-resolution functional mapping of non-coding sequences regulating fetal hemoglobin

High-resolution functional mapping of non-coding sequences regulating fetal hemoglobin
Transcriptional regulation from non-coding sequences and interacting DNA-binding transcription factors (TF)
govern the developmental switch from fetal to adult hemoglobin, commonly referred to as “hemoglobin
switching”. The reinduction of fetal hemoglobin (HbF) has been recognized as a promising therapeutic strategy
for β-hemoglobinopathies such as sickle-cell disease and β-thalassemia. Therefore, characterizing the cis-
regulatory logic of sequences regulating HBG1 and HBG2, the genes expressing the γ-globin chains of HbF, is
critical for understanding hemoglobin switching and developing more effective therapies. While population
genetics studies have identified functional single-nucleotide variants (SNVs) relevant for HbF induction, this
approach is limited to natural variation preventing comprehensive understanding of critical regulatory elements.
With the advent of CRISPR-Cas9 genome editing, targeted mutagenesis of regulatory sequences has been an
effective strategy for observing the functional consequence of variants unobserved in the population. Previous
studies have identified three erythroid-specific enhancers of BCL11A, an HbF repressor, and performed dense
SpCas9 nuclease dense mutagenesis throughout each enhancer, ultimately identifying a guide RNA (gRNA) hit
targeting a TF binding site causing potent re-induction of HbF, recently translated into an FDA-approved gene
therapy. However, due to limitations regarding the restrictive protospacer-adjacent motif, non-precise editing via
large insertions/deletions, and indirect readout of editing via guide RNA (gRNA) sequencing, the limited
resolution of these initial and subsequent studies prevent the comprehensive identification of HbF regulatory
elements. By directly addressing these limitations, I hypothesize that high-throughput, PAM-flexible dense base
editing of HbF regulatory sequences can elucidate the variant-level cis-regulatory logic and corresponding
transcription factor (TF) binding sites underpinning hemoglobin switching, therefore capturing biological insights
missed to date. Specifically, I will perform in-situ dense base-editing mutagenesis of three known erythroid-
specific BCL11A enhancers and the HBG promoter due to their therapeutic relevance for potent HbF reinduction.
To determine the variant-level cis-regulatory logic, I will perform two approaches: (Aim 1) I will indirectly
estimate per-variant enrichment scores by statistical modelling of gRNA enrichment and surrogate-editing
patterns using a gRNA sensor construct containing a target-mimicking “surrogate” sequence immediately
downstream of the gRNA, and (Aim 2) I will directly estimate per-variant enrichment scores by statistical
modelling of the allele enrichment from direct amplicon-sequencing of the target region. This work can uncover
new therapeutically relevant gRNAs for β-hemoglobinopathies and establish a general approach that can be
applied to study sequences regulating other therapeutically relevant phenotypes.

Public health relevance
Project Narrative: The reinduction of fetal hemoglobin is a therapeutic strategy for β-hemoglobinopathies such as sickle-cell disease and β-thalassemia. Characterizing the cis-regulatory logic of non-coding sequences that regulate fetal hemoglobin is critical for understanding hemoglobin switching and developing more effective therapies. Therefore, I will establish a high-resolution CRISPR mutagenesis approach to dissect the major non-coding sequences that regulate fetal hemoglobin.